Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT: PROJECT SUMMARY
The catchment area of Siteman Cancer Center (SCC) spans 82 counties across Missouri and Illinois. The
counties exhibit significantly different levels of health coverage and overall cancer burden. The population of the
catchment is extremely diverse, with 15% of the population living in a rural area, and 29% in a Medically
Underserved Area (MUA). Minority populations in the catchment make up 20.5% of the total population.
However, a significantly higher proportion of SCC patients who are African-American live in a MUA (31.3%),
compared to White patients (25.2%). Our catchment area as a whole carries a disproportionately high cancer
burden, with increased incidence of late stage diagnoses and a high cancer mortality. In fact, a significant
percentage of SCC catchment counties fall within the highest US quartile for breast, lung, prostate, and colorectal
cancer mortality. To address the disparities and cancer burden in our catchment, SCC investigators have
developed tailored educational materials, cancer-specific community partnerships, a clinical trial participation
monitoring system, and expanded clinical services as part of SCC’s Comprehensive Outreach Strategy. SCC’s
Community Outreach and Engagement (COE) component builds on this foundation with the goal to sustain
partnerships and assure that all cancer patients and communities can benefit from clinical and scientific
advances. SCC’s COE component addresses and monitors disparities among underserved populations,
specifically racial (minority), geography (rural), access to services (medically underserved areas), and their
interaction. SCC’s COE component is organized into an Internal Advisory Board (IAB); a Community Advisory
Board (CAB); a Clinical Studies Outreach (CSO) team; and six and one-half full-time equivalents staff. These
groups work together to accomplish the COE aims: (1) Monitor and evaluate the cancer burden and related
disparities in the SCC catchment; (2) Accelerate the implementation of outreach, education, and clinical
resources in collaboration with communities to reduce the cancer burden and related disparities in the SCC
catchment; and (3) Support research to reduce the cancer burden and related disparities in the SCC catchment
through: (3a) Support for community-based and health disparities research, and (3b) Continuous evaluation and
education to promote diversity in clinical trial participation. To achieve these aims, COE will build upon existing
strong community and regional partnerships that have emanated from SCC’s critical role as a provider and
research center in our catchment area. By achieving the above aims, SCC will ensure that the center is best
addressing the impact of cancer in our catchment and is developing a solid infrastructure for sustaining positive
impacts and strengthening translation of SCC research to clinical practice. Together, these aims work to reduce
the cancer burden and related disparities in SCC’s catchment.